Molecular Mechanisms

PROJECT SUMMARY/ABSTRACT MOLECULAR MECHANISMS CORE
The Pennington/Louisiana NORC promotes research under the theme of “Nutrition, Obesity, and Metabolic
Health through the Lifespan”. Within that theme, the NORC Molecular Mechanisms Core seeks to facilitate
research progress by providing NORC Members with access to modern biomedical research technology that
typically exceed the capabilities of individual laboratories, particularly those of investigators at the start of their
careers. To understand the molecular etiology that forms the pathogenic framework for obesity and metabolic
disease, technologies that capture gene expression -- the driving force of physiology and phenotype -- are of
primary necessity for conducting mechanistic research.
Therefore, the Molecular Mechanisms Core provides turn-key access to technologies assessing gene
expression to NORC investigators. These range from systems-biology level expression profiling in complex RNA
mixtures, single cell RNA sequencing to reveal cellular composition and tissue diversity based on gene
expression, to high power microscopy and three-dimensional imaging methods to locate gene products, and
determine where expression changes occur in response to external factors. Together, these methods provide
an integrated mechanistic perspective on how cell and tissue functions are affected by nutrition, obesity, or
metabolic disease.
The Core offers services built around the general experimental workflow that are organized in three Specific
Aims: consulting services on the experimental design and statistical considerations pertaining to molecular
bioimaging and functional genomics technology (Aim 1); expertise and direct technological support for
experiments (Aim 2); and data processing services and bioinformatics support for molecular bioimaging and
functional genomics experiments (Aim 3). Services in all three Aims are based on the expertise, skills, and
experience present in the Core leadership and staff, strict quality control measures and instrument maintenance,
full transparency in interaction with Core users, and the flexibility to customize protocols to suit the needs of
individual NORC-member projects. As the needs of NORC members change and as technology moves ahead,
the Core seeks to bring new methods online to serve the needs of current and future NORC investigators.